Retail Food Safety Consultation Service: Applying Behavior Change Models to Incre

Project Summary/Abstract The Lincoln-Lancaster County Health Department (LLCHD) Food Safety Program's primary goal is preventing foodborne illness through a comprehensive program based on the 2009 FDA Food Code and on FDA's Retail Program Standards. LLCHD retail food inspection trend data revealed that violations of key risk factors for foodborne illness had stabilized and a subset of establishments continued to have significantly higher numbers of Critical Item Violations. While many regulatory programs have worked with retail food industry to implement Active Managerial Controls (AMC), success has been limited. The goal of LLCHD's proposal is to reduce foodborne illness originating from retail food establishments and the outcome will be fewer illnesses, hospitalizations and deaths. LLCHD's objective is to strengthen AMCs of food safety at the retail level through implementing an innovative Retail Food Safety Consultation Service utilizing a two-part behavioral change intervention strategy. In part one, LLCHD will engage Food Protection Managers in a community- based social marketing initiative based on a scientifically proven community behavior change model developed by environmental psychologist McKenzie-Mohr - Fostering Sustainable Behavior Community-Based Social Marketing. LLCHD will coordinate a Food Managers for Excellence Task Force, whose charge will be to apply this model to increase the implementation of AMCs in retail food establishments. In part two, a Retail Food Safety Consultant will provide intensive on-site consultative intervention to Food Protection Managers in the poorest performing retail food establishments, resulting in the implementation of AMCs for FDA's Five Key Risk Factors for foodborne illness. LLCHD will collaborate with the retail food industry, State agencies, FDA, and the University of Nebraska-Lincoln in this project. This proposal provides a unique opportunity for FDA to test two proven behavior change models that have had limited application in retail food regulatory programs. If successful, this model will change the field of practice and provide new strategies to achieve a higher level of retail food safety across the U.S., reducing foodborne illness.

Public health relevance
Project Narrative The overarching goal of the Lincoln-Lancaster County Health Department's proposal is to reduce foodborne illness originating from regulated retail food establishments. The main objective is to strengthen Active Managerial Controls of food safety at the retail level through implementing an innovative Retail Food Safety Consultation Service utilizing a two-part behavioral change intervention strategy: 1. Engage Food Protection Managers in a Community-based Social Marketing Initiative; and 2. Develop a Retail Food Safety Consultant Intensive On-site Intervention. This proposal provides a unique opportunity for FDA to test two behavior change models that have had limited application in retail food regulatory programs. __SpecificAimsTextDelimiter__ Specific Aims The Lincoln-Lancaster County Health Department (LLCHD) Food Safety Program's primary goal is preventing foodborne illnesses and deaths and is based on the 2009 FDA Food Code and FDA's Retail Program Standards. LLCHD enrolled in the Standards in 2001 and is in audited compliance with Standards 1, 2, 3, 5, 7, and 9. Analysis of LLCHD food inspection trend data revealed that critical item violations of key risk factors that present the greatest risk of foodborne illness has stabilized over the past few years. In addition, a small subset of retail food establishments continues to have significantly higher numbers of Critical Item Violations (CIV) than other facilities. While many regulatory programs have worked to help the retail food industry implement Active Managerial Controls (AMC), success has been limited or not long lasting. LLHCD is proposing to use innovative, proven community behavior change models to achieve successful implementation of AMCs in the retail food industry resulting in broader reaching and more sustainable outcomes. The overarching goal of LLCHD's proposal is to reduce foodborne illness originating from regulated retail food establishments. The expected outcome of this work will be fewer illnesses, hospitalizations and deaths due to foodborne illness. LLCHD's main objective for this proposal is to strengthen Active Managerial Controls of food safety at the retail level through implementing an innovative Retail Food Safety Consultation Service utilizing a two-part behavioral change intervention strategy: 1. Engage Food Protection Managers in a Community-based Social Marketing Initiative; and 2. Develop a Retail Food Safety Consultant Intensive On-site Intervention. Part one will be based on a scientifically proven community behavior change model developed by environmental psychologist McKenzie-Mohr - Fostering Sustainable Behavior Community-Based Social Marketing. Community-based social marketing has demonstrated that behavior change is most effectively achieved through initiatives delivered at the local community level which focus on removing barriers to an activity while simultaneously enhancing the benefits. LLCHD will coordinate a "Food Managers for Excellence" Task Force, whose charge will be to apply this model to increase the implementation of AMCs in retail food establishments. In part two, a Retail Food Safety Consultant will provide intensive on-site consultative intervention to Food Protection Managers in the poorest performing retail food establishments to increase implementation of AMCs for FDA's "Five Key Risk Factors" for foodborne illness. This proposal provides a unique opportunity for FDA to test two behavior change models that have had limited application in retail food regulatory programs. If successful, this model will change the field of practice and provide new strategies to achieve a higher level of retail food safety across the U.S., reducing foodborne illness. LLCHD will collaborate with the retail food industry, State agencies, FDA, and the University of Nebraska-Lincoln in this project. Since strategies will be based on changing behaviors, sustainable, long term outcomes are expected: fewer illnesses, hospitalizations and deaths due to foodborne illness.